Mechanisms of TNFa Enhancement of Nicotinic Receptor Upregulation

DESCRIPTION (provided by applicant): Nicotine imparts its effects on cellular function through interaction with neuronal nicotinic acetylcholine receptors (nAChR). Some of these receptors, especially those composed of α4β2 subunits, respond to sustained ligand exposure through the process of upregulation as defined by a substantial increase in the density of high affinity nicotine binding sites. The physiological consequences of upregulation have been linked to many diverse processes ranging from addiction to pathophysiological processes contributing to early phases of Alzheimer's disease. An exciting and relatively new role for nAChRs is emerging with regard to the interaction with pro-inflammatory cytokines. In fact, the anti-inflammatory properties of nicotine, acting through various nAChRs, is now widely reported to influence many diseases of inflammatory etiology. However, relatively little is known about the mechanisms controlling the inflammatory:nAChR interaction. The overall goal of this proposal is to define intracellular mechanisms that regulate the interactions between key pro-inflammatory cytokines and defined combinations of nAChR subtypes. SPECIFIC AIM 1. Hypothesis: TNFα-activation of the p38MAPK pathway and/or IL-1β activation of PKA pathways enhance α4β2 expression and these are antagonized by pathways involving PI3K/Akt signaling. In this Aim we will pursue the definition of intracellular pathways initiated by TNFα and/or IL-1β to enhance nicotine-mediated upregulation of nAChR?α4β2. SPECIFIC AIM 2. Hypothesis: Direct phosphorylation of α4 and the presence of other nAChR subunits modify the pro-inflammatory cytokine signals mediating enhanced upregulation of α4β2. This Aim will determine the impact of: 1) modifying PKA phosphorylation sites in α4;2) introducing (or deleting) other nAChRs (specifically α7 or α5);and 3) determining effects of TNFα or IL-1β intracellular signaling leading to enhanced α4β2 upregulation in cultured neurons. SPECIFIC AIM 3. Hypothesis: Interactions between cells of the CNS such as neurons and microglia (Mg) direct the outcome of the overall inflammatory:nAChR response. Neurons and microglia will be co-cultured in different ratios to dissect the relative contribution of paracrine, autocrine or juxtacrine interactions in modulating the TNFα and IL-1β-mediated enhancement of α4β2-upregulation in a mixed cell system. PUBLIC HEALTH RELEVANCE: We are interested in understanding the interaction between nicotine and inflammation. We will determine the signal transduction pathways cytokines use to promote or inhibit enhanced upregulation of nicotinic receptors. Two major cytokines, tumor necrosis factor alpha (TNFα) and interleukin-1β (IL-1β) enhance nicotine-induced upregulation of the high affinity nicotine receptor termed nAChRα4β2. The upregulation response is correlated with addiction behaviors and multiple pathologies of the brain such as Alzheimer's disease. Understanding how the inflammatory system and response to nicotine interact will impact upon how we approach these problems with therapeutic agents.

Public health relevance
Narrative We are interested in understanding the interaction between nicotine and inflammation. We will determine the signal transduction pathways cytokines use to promote or inhibit enhanced upregulation of nicotinic receptors. Two major cytokines, tumor necrosis factor alpha (TNFa) and interleukin-1b (IL-1b) enhance nicotine-induced upregulation of the high affinity nicotine receptor termed nAChRa4b2. The upregulation response is correlated with addiction behaviors and multiple pathologies of the brain such as Alzheimer's disease. Understanding how the inflammatory system and response to nicotine interact will impact upon how we approach these problems with therapeutic agents.